Novel Methods to Assess the Effects of Chemicals on Child Development

DESCRIPTION (provided by applicant) The primary goals of this Children's Center are to use a multidisciplinary approach to address critical gaps in our knowledge about the impact of exposure to endocrine disrupting chemicals (phthalates/BPA) on child development, to actively involve junior investigators in this research effort, and to actively communicate our research findings to parents, childcare providers and healthcare providers. There are three common themes that unite the three research projects and the Outreach and Translation Core (COTC) of this Center: (1) assessment of exposures during two critical developmental windows (prenatal and adolescent), (2) investigation of joint effects of phthalate/BPA exposure and a high fat diet/obesity, and (3) investigation of the role of oxidative stress and inflammation in mediating effects. At the heart of the research effort will be two human cohorts (Project 1)-a prospective pre-birth cohort currently in progress in Urbana, Illinois and an adolescent cohort to be assessed as part of a long-standing prospective study in New Bedford, Massachusetts. The Center will also include laboratory animal projects (Projects 2 and 3) which will model the timing of exposures in these human cohorts, a COTC, and this administrative core which will provide oversight, coordination and integration of all Center-related activities. The responsibilities of the Administrative Core will include organizing and scheduling monthly meetings of the Internal Advisory Committee and monthly research team meetings of the Center investigators, organizing yearly meetings of the Center scientists with the six-member External Advisory Committee, coordinating the career development activities of the Center, and facilitating interactions of the Pediatric Health Specialist with the COTC to communicate research findings to the healthcare community. As Director and Associate Director of the Children's Center, Drs. Susan Schantz and Jodi Flaws will be responsible for conducting Internal and External Advisory Committee meetings and regularly evaluating the research progress of each of the projects, as well as the outreach activities of the COTC. They will also be responsible for general fiscal oversight of the Center. Dr. Flaws will have full authority to make decisions in Dr. Schantz's absence. Relevance: Phthalates and BPA are endocrine disrupting chemicals that are found in many consumer products. Exposure is widespread, but the impact of this exposure on child health and development is not well-understood. This Center's research will fill an important gap in our knowledge by investigating the effects of these chemicals, both alone and combination with a high fat diet on reproductive and neural development.